Cytoskeletal Function in C. elegans Embryos

Project Summary
Alyssa will use molecular genetics and high resolution light microscopy to further advance her
discovery that microtubules are an integral component of the C. elegans oocyte cortex, where
they serve to stiffen the cortex and thereby limit the extent of membrane ingressions during
oocyte meiotic cell division and polar body extrusion. Through additional training, Alyssa will
acquire extensive new skills in molecular genetics (optogenetics, gene replacement and
genome editing) and microscopy (near TIRF, Zeiss Airyscan, and Nikon Spinning Disk SoRa
microscopy). She also will gain extensive experience in collaborative, interdisciplinary research
with our Imaging Facility Dr. Adam Fries and senior research associates in my lab, and with the
undergraduates that she will mentor during her thesis work. Alyssa also will focus more on
networking, particularly by attending multiple science conferences over the next two years.
Finally, Alyssa will gain extensive additional writing and speaking experience, as these are the
areas in which she most needs improvement. By being able to devote all of her time to lab work,
without having to teach due to my insufficient budget for the remaining year of my current MIRA
funding, Alyssa will be far more likely to excel with multiple publications and improvements in
writing and speaking that will greatly improve her ability to succeed in career as an independent
investigator.

Public health relevance
Project Narrative Alyssa Quiogue is a third year Ph.D. student who will gain important additional training by further pursuing her discovery that microtubules are an integral component of the C. elegans oocyte cortex, where they function to stiffen the cortex and modulate membrane ingression during oocyte meiotic cell division. This supplement will provide support for Alyssa from July 1, 2023 (when she will no longer be supported by an NIH Development Training Grant) until the end of my current MIRA funding on May 31, 2024. She will benefit from additional training in cutting edge molecular genetics and microscopy, from networking efforts to make up for the isolation of Covid, and from further important experience in writing and speaking.